A SYSTEM FOR ANALYSIS OF GENE CONTROL IN DROSOPHILA

We are attempting to understand the mechanism of gene control in higher organisms by focusing on the expression of the gene that codes for alcohol dehydrogenase in Drosophila melanogaster. Using a variety of biochemical and molecular techniques, we are studying several mutants that lack alcohol dehydrogenase activity. One class of such mutants seems not to synthesize an alcohol dehydrogenase-like protein, even though these mutants have the Adh-gene and make substantial amounts of a mRNA that reacts with an Adh-gene probe. We are currently cloning all the representatives in this class of mutants and hope, by DNA sequencing, to determine what causes this molecular phenotype.